Optical Coherence Tomography (OCT)-Guided Ultrafast, Nonthermal Laser Microablation for Non-invasive Vitreoretinal Surgery

PROJECT SUMMARY
Photonics research has substantially advanced ophthalmology by introducing precise diagnostic and treatment methods
that have enhanced eye health and vision outcomes. Thermal lasers have revolutionized the treatment of posterior
segment conditions such as diabetic retinopathy, age-related macular degeneration, and retinal detachments; however,
their application is limited near the macula—the central part of the retina—due to the risk of irreversible loss of vision
from collateral thermal damage. This project aims to develop the next generation of surgical techniques by evaluating
the usability of ultrafast (femtosecond) nonthermal lasers for treating vitreoretinal and posterior segment disorders of
the eye.
Ultrafast lasers are widely used in anterior segment LASIK and cataract operations, yet their application in vitreoretinal
cases remains unexplored. In the U.S., around 250,000 pars plana vitrectomies (PPV) are performed annually, serving as
the standard treatment for most vitreoretinal conditions. While effective, PPV is a delicate and time-consuming
operation, carrying the risk of potential iatrogenic complications. The use of nonthermal femtosecond lasers as a “laser
scalpel” presents the exciting possibility to enable rapid and highly precise surgery with significantly less error-prone
manual operations within the eye.
Changes in the vitreous gel's properties either due to normal aging processes or pathological sequelae of common
chronic disorders, such as diabetic retinopathy, can lead to anomalous scar tissue or epiretinal membrane (ERM)
formation on the vitreoretinal interface. These changes cause significant vision distortions and can lead to mechanical
vitreomacular traction (VMT), which commonly leads to retinal holes and tears. The central hypothesis is that the
integration of ultrafast nonthermal laser ablation, guided by real-time optical coherence tomography (OCT) imaging
and an artificial intelligence (AI)-enhanced interface, will facilitate noninvasive, non-thermal interventions for VMT
and ERM, presenting an alternative to PPV which can more reliably preserve the integrity of adjacent critical retinal
structures.
Aim 1: Characterization of ultrafast laser ablation effects on ex vivo vitreous and retinal tissues and development of
integrated OCT-laser system.
Aim 2: Development of 3D segmentation AI algorithms and a surgical operator interface for guiding treatment.
Aim 3: Validation of the integrated system through testing on whole ex vivo porcine and cadaver human eyes.
These studies pave the way for revolutionary advancements in the minimally invasive treatment of vitreoretinal
disorders. This training plan’s focus on laser and imaging techniques integrates well with a career goal of becoming an
ophthalmologist-scientist with a focus on developing novel biophotonics-based diagnostic and therapeutic techniques.

Public health relevance
PROJECT NARRATIVE Pars plana vitrectomy, the current gold-standard surgical treatment for vitreoretinal disorders, remains manual, invasive, time-consuming, and carries a significant risk of complications. This project aims to pioneer the first vitreoretinal application of nonthermal femtosecond lasers, integrated with optical coherence tomography and artificial intelligence technology, to offer a minimally invasive, yet highly effective treatment method for vision-threatening vitreoretinal and posterior segment disorders. The goals of this approach could drastically reduce the recovery time and incidence of iatrogenic complications associated with conventional approaches, consistent with the mission of the National Eye Institute, which is to “eliminate vision loss” and “improve quality of life through vision research”.